Cell specific delivery of novel therapies to enhance glomerular regeneration and repair

PROJECT SUMMARY/ABSTRACT
The goal of this project is to change the treatment paradigm for proteinuric glomerular diseases by combining
therapeutics development with cell-specific delivery to enhance podocyte repair and regeneration in vivo.
Podocytes, highly specialized terminally differentiated epithelial cells, are injured in the majority of
glomerular diseases. As podocytes cannot self-renew, podocyte loss leads to glomerular scarring. A
subpopulation of parietal epithelial cells (PECs) can serve as podocyte stem cells (`PEC progenitors'), but their
regenerative potential is insufficient to overcome disease-associated glomerular damage. Enhancing
productive repair of podocytes thus requires a dual synchronized approach: (i) replacing lost podocytes to
increase their number, and (ii) limiting/reversing damage to the remaining podocytes. However, major
knowledge gaps prevent us from achieving these goals; these include our limited knowledge on the molecular
factors stimulating PEC self-renewal and podocyte regeneration/repair, as well as options methods for
delivering these factors to specific kidney cell types in vivo.
Our team of four expert investigators will wield complementary tools to close these knowledge gaps and
produce innovative therapies. Dr. Wessely will apply Design of Experiment (DoE) approaches to identify novel
combinations of molecules that increase PEC progenitors and reduce podocyte loss; Dr. Roberts will conjugate
these therapeutics to VHHs (nanobodies) for delivery to PEC progenitors and podocytes; Dr. Freedman will
generate gene-edited human kidney organoids to validate effects of VHHs compared to clinical data from
patients; Dr. Shankland will use lineage tracing animal models of podocyte depletion and human organoids
transplanted into mouse kidneys for in vivo safety and efficacy analysis. This pipeline will ultimately test the
hypothesis that targeted delivery of PEC- and podocyte-specific therapeutic cargos can enhance podocyte
repair and regeneration in vivo, and restore glomerular function to below the clinical disease threshold.
The work will be accomplished through two Specific Aims, each with unique Milestones. The first Aim is to
increase glomerular regeneration in vivo by cell targeted delivery of novel combinations of peptides and small
molecules to augment podocyte progenitors of parietal epithelial cell origin. The second Aim is to increase
productive repair of damaged podocytes by cell-type specific delivery of newly identified therapies. For both
aims, we will employ the above pipeline to discover candidate therapeutics by DoE and cross-referenced with
glomerular disease signatures from human patients. These will be combined with cell type-specific VHHs from
high diversity recombinant VHH libraries to selectively deliver them to human PECs (Aim 1), or podocytes (Aim
2). Enhanced regeneration in vivo will be demonstrated in animal models of FSGS and transplanted human
organoids. This process will establish a new paradigm for the treatment of kidney disease, and produce lead
therapeutic candidates for further pre-clinical development and ultimately human clinical trials.

Public health relevance
PROJECT NARRATIVE The goal of this project is to change the treatment paradigm for diseases affecting the podocytes, cells that physically filter the blood to form the urine, by combining therapeutics development with cell-specific delivery to enhance the natural ability of the body to repair and regenerate these highly specialized cells. Accomplishing this requires a dual synchronized approach: (i) replacing lost podocytes from neighboring stem cells to increase their number, and (ii) limiting/reversing damage to the remaining podocytes, however, major knowledge gaps to achieve this goal exist, including our limited knowledge on the molecular factors stimulating PEC self-renewal and podocyte regeneration/repair, as well as options to deliver such factors to specific kidney cell types in vivo. By establishing a pipeline through which we couple cutting-edge cell delivery molecules called nanobodies to recently-discovered factors that protect damaged podocytes and promote the replacement of lost ones, we will create a new family of therapeutic entities that prevent disease in both mouse and human kidney tissue, by harnessing the body's natural abilities to regenerate this vulnerable kidney compartment.